Clinical and Translational Research Core

The objectives of the Clinical Core have not changed since its initial proposal. The overarching goal of the Clinical Core is to facilitate translations! and patient-oriented research. The Clinical Translational Core aims to develop an infrastructure for patient-oriented research by streamlining regulatory compliance, attaining high-quality samples linked to large clinical phenotypic information through integration of diverse databases and, innovative application of statistical tools.